Immunoregulatory roles for exosomes in the gastrointestinal tract

PROJECT ABSTRACT
Intestinal homeostasis, which is paramount to maintaining human health and preventing inflammatory bowel
diseases (IBDs), relies on the ability of the immune system to react to pathogens while tolerating commensal
microbes. Although much has been learned regarding the mechanisms that regulate immunity at this mucosal
site, this system is quite complex and many aspects of how the host ensures proper responses remain elusive.
Recent work indicates that various cells of the immune system utilize a novel mode of communication that is
mediated by small lipid extracellular vesicles (EVs), including exosomes. Following their release from cells,
exosomes have been shown to bind target recipient cells and deliver their cargo, including microRNAs
(miRNAs), to change cellular functions. Despite decades of knowing that exosomes exist, work in this field has
been hampered by a lack of mouse mutants that have impaired exosome production. Moreover, even less is
known about the functional roles of exosomes within the gut. Recently, the small GTPases Rab27a/b have
been shown to be critical for the release of exosomes, and dysregulated expression of Rab27 is associated
with human colitis and colon cancer. Our preliminary data indicate that genetic deletion of Rab27a in CD11c+
macrophages (Macs) and dendritic cells (DCs) leads to inflammation in the gastrointestinal (GI) tract, while
injection of dendritic cell exosomes containing miRNAs can rescue this phenotype. We hypothesize that
Rab27a-dependent, Ybx1-loaded exosomes produced by Cd11c+ Macs/DCs of the GI tract regulate
inflammation during colitis by delivering specific regulatory miRNAs to gut cells. We will carry out the following
aims to explore this prediction and gain a deeper understanding about the functional relevance of exosomes in
the prevention of intestinal inflammation. Aim 1 will determine functionally relevant CD11c+ exosome
producing Mac/DC cell subsets during intestinal inflammation. Aim 2 will determine the role of Ybx1 during
colitis, and its contribution to CD11c+ Mac/DC exosome contents. Aim 3 will determine the functional
consequences of CD11c+ Mac/DC exosome delivery of specific miRNAs to cells of the GI tract during colitis.
This work will lead to groundbreaking insights into the roles played by EVs in the GI tract during human health
and disease.

Public health relevance
Project Narrative Proper control of inflammation within the gastrointestinal (GI) tract is critical for human health, yet many aspects of how this is regulated remain unclear. We will investigate the role of small lipid extracellular vesicles called exosomes in conferring immune regulation in the GI tract during health and inflammatory disease. This work will contribute to the development of novel biomarker and therapeutic strategies for inflammatory bowel disease that involve exosomes and their cargo.